Dynamic relations between interpersonal stressors, affective states, and binge eating in adolescent girls

Project Summary/Abstract
Binge-spectrum eating disorders (BSEDs; e.g., bulimia nervosa and binge eating disorder) are serious mental
health disorders that are prevalent among adolescents. The defining feature and primary treatment target for
BSEDs is recurrent episodes of binge eating (BE; i.e., overeating while experiencing a loss of control over
one’s eating). Despite a need to intervene on BE during adolescence to reduce long-lasting deleterious
psychosocial and physical health outcomes, outcomes from existing treatments are suboptimal, possibly
because the maintenance factors of BE during adolescence are poorly understood and available treatments
may not effectively target the most potent mechanisms. Thus, research is urgently needed to identify novel
mechanisms of adolescent BE to advance the development of interventions. Adolescence is a period
characterized by significant social and emotional change. Consequently, adolescents display heightened
sensitivity to social evaluation, and the quality of adolescent social relationships is robustly linked to mental
health outcomes. Adolescence is also a critical period for socioemotional learning and the development of
abilities to regulate negative affect, which is theorized to maintain BE. Thus, one theory of BE that may be
particularly relevant during adolescence is the interpersonal model, which proposes that interpersonal
stressors predict BE, and this relationship is mediated by increases in negative affect. Harnessing digital
assessment tools and advanced statistical methods has the potential to examine the interpersonal model and
identify intervention targets by: 1) Testing the interpersonal model on a momentary level in adolescents’ natural
environments to uncover temporal relations between interpersonal stressors, affective states, and adolescent
BE and reveal opportune moments for support; 2) Exploring heterogeneity within the interpersonal model
based on key individual characteristics (i.e., dietary restraint and emotion regulation) to inform the development
of personalized interventions; and 3) Exploring how specific types of interpersonal stressors (e.g., peer
rejection, parental conflict) and affective states (e.g., anger, embarrassment) may differentially contribute to BE
within the interpersonal model, which could serve to refine theories of adolescent BE and inform tailored
intervention approaches. The proposed study will employ ecological momentary assessment (EMA) to
examine temporal relations between interpersonal stressors, affective states, and BE among 30 adolescent
(ages 14-18) girls with BSEDs. We will test the prospective effects of experiencing an interpersonal stressor on
BE and examine the mediating role of negative affect. We will also examine if the strength of the relationships
between interpersonal stressors, negative affect, and BE varies based on dietary restraint and emotion
regulation. Exploratory analyses will examine the relative temporal effects of specific types of interpersonal
stressors and specific affective states on BE. This study has the potential to significantly advance
understanding of mechanisms of adolescent BE and inform the development of novel, real-time interventions.

Public health relevance
Project Narrative Binge eating (BE; i.e., overeating while experiencing a loss of control over eating) is the defining feature of binge-spectrum eating disorders (e.g., bulimia nervosa and binge eating disorder), which typically onset and show peak prevalence during adolescence. Given the importance of interpersonal influences and socioemotional development during adolescence, a promising theory of BE in adolescence posits that experiencing interpersonal stressors predicts BE eating and this relationship is mediated by increases in negative affect. To inform targets for novel, real-time interventions, the proposed study will examine momentary relations between interpersonal stressors, affective states, and BE among adolescent girls with binge-spectrum eating disorders.